Dynamic regulation of neuroinflammation and IL-1b-trap

PROJECT SUMMARY
IL-1 is a master neuroimmune regulator. IL-1 activity is important for both physiological functions
of the brain and pathogenesis of all CNS diseases. The cellular sources of IL-1 are not well
defined and genetic access to manipulating IL-1-expressing cells is lacking. We have created
an IL-1-trap mouse to visualize IL-1 expressing cells. In addition, we can inhibit or activate IL-
1-expressing cells by chemogenetic methods. Using this new tool, we will: 1) demonstrate
distinct sets of cells express IL-1 in homeostasis and in different neuroimmune activation
conditions; 2) determine the role of homeostatic IL-1-expressing cells on the neurochemical and
behavioral consequences following peripheral and central inflammatory challenge; and 3)
determine the role of the induced IL-1-expressing cells on the neurochemical and behavioral
consequences following peripheral and central inflammatory challenges.

Public health relevance
PROJECT NARRATIVE This study investigates the use of our newly invented IL-1-trap mice to map IL-1-expressing cells in the brain under various conditions. This animal will also be used to specifically inhibit or activate IL-1-expressing cells to manipulate neuroinflammation. The results could establish a very useful tool for neuroimmune research and discover discrete immune circuits in the brain.